Structured quantification of inherited macular disease phenotypes as the basis for automated algorithms to determine causal genes

PROJECT SUMMARY/ABSTRACT
The ability to obtain a molecular diagnosis in patients by genetic testing is an essential step towards
understanding the etiology and treatment prospects for a monogenic disease. Recently, genetic testing has
become increasingly accessible for patients due to technical advances in sequencing, however, genetic testing
outcomes in many cases are often inconclusive. One major underlying reason for this is that identifying the
precise causal gene of a monogenic disorder based solely on the interpretation of variant pathogenicity is
challenging due to the profound complexity of the human genome and its mutational landscape. The
corresponding phenotypic landscape in patients exhibits just as much (if not more) complexity however these
clinical insights are underutilized in the pursuit of molecular diagnoses. The overall goal of this proposal is to
characterize critical differences in the clinical manifestations of various inherited macular dystrophy (IMD) genes
and develop a molecular diagnosis prediction tool to improve genetic testing outcomes. In Specific Aim 1, we will
assemble a large multi-IMD gene cohort of patients in which we will acquire a comprehensive set of phenotypic
data using advanced retinal imaging modalities. The causal gene in each patient will be confirmed by whole
exome sequencing (WES) and analysis using a modified diagnostic pipeline specifically tailored to IMD genes.
In Specific Aim 2, we will (1) evaluate differences in the pattern of retinal pigment epithelium loss relative to
photoreceptor loss in the degenerating macular lesions of each eye using comparative, cell type-specific fundus
autofluorescence imaging, (2) measure early sub-clinical photoreceptor layer thinning across the macula with
transverse swept-source optical coherence tomography and (3) compare morphometric characteristics of sub-
retinal fundus deposition found across various IMD genes. In Specific Aim 3, we will identify and determine ways
to statistically differentiate “diagnostically ambiguous phenotypes” (DAP) shared between IMD genes and
integrate these findings into a computational model that predicts and algorithmically ranks candidate genes
based on fundus findings in an individual patient. Lastly, this model will be tested and validated in a separate
IMD cohort to evaluate its efficacy in aiding genetic testing in a standard clinical setting.

Public health relevance
PROJECT NARRATIVE The ability to obtain a molecular diagnosis in patients is essential for understanding the cellular etiology, clinical prognosis, and treatment prospects of inherited macular dystrophy —a heterogeneous group of genetic disorders characterized by progressive central vision loss. Genetic testing has recently become more accessible to patients with IMD, however, testing outcomes are often inconclusive due to the difficult task of identifying a single causal gene across the immense and complex landscape of the human genome. Using advanced diagnostic retinal imaging modalities, this research proposal will decipher precise phenotypic differences between IMD genes and create a prediction tool to help improve genetic testing outcomes for patients.